Molecular and Cell Biology Resources Core

MOLECULAR AND CELL BIOLOGY RESOURCES CORE (MCBRC)-SUMMARY
The Molecular and Cell Biology Resources Core (MCBRC) utilizes existing facilities within LSU
A&M campus and other research-intensive institutions in Louisiana including three major medical
centers to support faculty, staff, and students at primarily undergraduate institutions (PUIs).
MCBRC is administered by the School of Veterinary Medicine's Division of Biotechnology and
Molecular Medicine (BioMMed) to provide access to core facilities offering expertise in gene
expression, protein production, immunology, pathology, and microscopy. MCBRC facilitates
access to various resources across Louisiana and coordinates with NIH-funded COBRE Centers
for Pre-Clinical Cancer Research (CPCCR) and Lung Biology and Disease (CLBD)
headquartered at the LSU School of Veterinary Medicine. It maintains a database of specialized
equipment within LSU A&M and other research-intensive institutions in Louisiana and provides
wet lab space and vivarium access for LBRN investigators conducting animal experiments at
dedicated laboratories at LSU. Specific aims include providing resources and expertise in
molecular and cell biology technologies, training and supporting LBRN investigators, and fostering
interactions among researchers. MCBRC's centralized equipment, services, and training
capabilities enhance molecular and cell biology and immunopathology research, maximizing
efficiency and aiding PUIs in adopting new technologies for in vitro and in vivo studies using
experimental animal model systems. Also, MCBRC facilitates access of equipment and resources
available by the collaborating research-intensive institutions.